Chemistry Center for Combatting Antibiotic-Resistant Bacteria (CC4CARB)

The Chemistry Center for Combating Antibiotic-Resistant Bacteria (CC4CARB) will synthesize and deliver rationally designed compound libraries to the scientific community to facilitate antibacterial drug discovery efforts, particularly those targeting Gram-negative bacteria.